Progesterone and allopregnanolone of prefrontal cortical activity dynamics and heroin seeking

ABSTRACT: To develop treatments, it is vital to identify neural mechanisms underlying relapse in opioid use
disorder. To dissect neural activity underlying relapse, we developed a novel assay allowing for in vivo two-
photon calcium imaging while head-fixed mice engage in heroin self-administration. Using this approach, we
find global excitatory activity in the prelimbic-prefrontal cortex (PrL) decreases with acquisition of heroin
seeking, an effect that persists through extinction, but then resurges during reinstatement. These dysregulated
global PrL dynamics mirror clinical observations that are considered hallmarks of substance use disorder.
Importantly, our approach has identified, for the first time, that PrL activity dynamics emerging during
acquisition, extinction, and reinstatement are heterogenous, with distinct ensembles exhibiting unique
excitatory and inhibitory activity dynamics aligned with behavioral epochs. How these unique activity dynamics
guide drug seeking, however, is unknown. This implies greater resolution of PrL activity dynamics is necessary
to determine how they functionally regulate behavior. Here, under the expert guidance of Drs. Jim Otis and
Peter Kalivas, my K99 training in advanced computational neural analyses and single-cell optogenetics paired
with in vivo calcium imaging will resolve the function of discrete PrL ensemble dynamics for relapse (Aim 1).
Notably, there are subpopulations of individuals with substance use disorder in whom relapse may
emerge through different neurobiological mechanisms. Females form one such subpopulation, as they exhibit
enhanced relapse vulnerability and greater prefrontal activity during craving and relapse compared to males.
However, this vulnerability covaries with the ovarian hormone cycle, such that peak circulating levels of
progesterone (PROG) appear protective. These effects are mediated by its 5alpha-reductase neuroactive steroid
metabolite, allopregnanolone (ALLO), which can influence prefrontal circuitry and promote adaptive responding
in females. As ALLO acts as a positive allosteric modulator at GABA-A receptors, it likely constrains PrL neuronal
activity to suppress drug seeking. As I find ALLO can act directly within PrL to suppress heroin-seeking
reinstatement, I hypothesize that PROG and ALLO can disrupt PrL activity dynamics which functionally guide
reinstatement. During the R00 phase, my career goal to be an independent investigator will involve building a
research program wherein I resolve the influence of PROG and ALLO on PrL activity dynamics during
reinstatement using in vivo two-photon calcium imaging. As activation of PrL projections to the nucleus
accumbens core (NAcC) is necessary for reinstatement, I will retro-label PrL-NAcC neurons to enable
simultaneous monitoring of global PrL and PrL-NAcC ensembles (Aim 2). Using single-cell optogenetic and
circuit labelling approaches, I will assess the functional influence of PROG and ALLO on PrL and PrL-NAcC
ensembles for reinstatement (Aims 2-3). As I find ALLO but not PROG suppresses reinstatement in males, I will
assess steroidal effects on PrL and PrL-NAcC ensemble activity dynamics as a function of biological sex.

Public health relevance
PROJECT NARRATIVE: In this proposal we investigate the function of discrete neuronal activity dynamics that emerge in the prefrontal cortex while animals reinstate heroin seeking, and how such activity is modulated by both progesterone and its metabolite allopregnanolone as they suppress reinstatement. The proposed research is relevant to public health as elucidating the precise mechanisms underlying drug-seeking behavior can guide development of more effective treatment approaches for opioid use disorder. The proposed research is, furthermore, relevant to NIH's mission as it pertains to developing fundamental knowledge that will contribute to the understanding of neural circuits that underlie motivated behaviors.